Using Digital Health Technology to Prevent Bullying and Cyberbullying among Elementary School Students

ABSTRACT
Bullying and cyberbullying are highly prevalent forms of aggressive behavior among youth of all ages and have
a wide variety of negative social and mental health consequences. Bullying in all its forms involves persistent
and intentional threatening, aggressive or verbally abusive behavior directed toward others at relative
disadvantage. These behaviors share a similar set of risk and protective factors with early-stage substance use,
therefore a single intervention approach may efficiently address both behaviors. Indeed, a fruitful way to extend
the benefits of evidence-based prevention is to adapt the most effective interventions so they address shared
and unique risk and protective factors for multiple related behaviors. The proposed SBIR Fast-Track application
requests funding to develop and evaluate a multicomponent intervention to prevent bullying behavior by
adapting the evidence-based Life Skills Training (LST) elementary school program. LST teaches youth personal
self-management skills, social skills, drug refusal skills, and other life skills needed to successfully navigate key
developmental tasks, increase resilience, and facilitate healthy psychosocial development. The LST program
has been extensively tested and found to effectively prevent substance use in a series of randomized controlled
trials with behavioral effects reported in over 30 peer-reviewed publications. The intervention for the proposed
SBIR will teach young people how to respond to in-person and online bullying from the perspectives of
perpetrator, victim, and bystander. We propose to develop: (1) bullying-specific classroom sessions to
supplement the existing LST elementary school program; (2) an immersive serious (educational) video game to
provide opportunities for students to apply life skills in preventing bullying and other high-risk situations in a
gamified format; (3) e-learning modules that provide parents with strategies and resources to support anti-
bullying lessons taught in school; and, (4) e-learning modules for educators and support professionals that
emphasize the importance of a school-wide anti-bullying approach that teaches prosocial behavior and
encourages respect for peers. In Phase I, we will develop prototypes of bullying-specific classroom sessions, a
video game level, and teacher and parent training materials to test them for feasibility, usability, and overall
appeal. In Phase II, we will complete the development of all program materials and conduct a rigorous
randomized controlled trial (RCT) of the prevention program. Elementary schools (N=30) will be randomized to
either an intervention group that receives the prevention program or a treatment-as-usual control group that
receives existing school health education. At the end of the initial intervention period, and at one- and two-year
follow-ups, we will compare both groups with respect to changes in behaviors, norms, attitudes, and knowledge
regarding bullying, cyberbullying, and substance use behavior. The goal of this SBIR is to develop commercial-
quality bullying prevention products that incorporate digital health technology and are flexible, effective, and
easy-to-use, and can be widely-disseminated to elementary schools in the US.

Public health relevance
NARRATIVE This Fast-Track SBIR proposal is designed to address the critical public health problem of bullying and cyberbullying among elementary school age youth. We will develop and test bullying and cyberbullying prevention materials, including interactive classroom sessions and corresponding serious games, based on the evidence-based Life Skills Training substance abuse prevention approach, which teaches personal self- management skills, social skills, refusal skills, and other life skills needed to successfully navigate developmental tasks, increase resilience, and facilitate healthy psychosocial development. The proposed product has the potential to fill a gap in the intervention tools currently available to schools that can be widely disseminated throughout the country using existing marketing and dissemination channels and decrease the adverse consequences of bullying, cyberbullying as well as substance abuse.